Gene Modulation inCancer Cellular Models

PROJECT SUMMARY: Gene Modulation in Cancer Cell Models (GMCCM) Shared Resource
The complexity and heterogeneity of cancer demand appropriate and adaptable cell-based models that enable
researchers to uncover key genes, pathways, interactions, and modifications that drive cancer development
and to devise effective and personalized therapeutics. The Gene Modulation in Cancer Cell Models (GMCCM)
Shared Resource provides DLDCCC members with a versatile combination of cutting-edge technologies,
genomic resources, and advanced instrumentation. Directed by Drs. Dan Liu and Jean Kim, who combined
have extensive expertise in developing technologies and cancer cell models (e.g., high-throughput genetic
screens and stem cell manipulation), GMCCM houses essential elements for single-gene analyses to whole-
genome screens, including genome-wide libraries of short-hairpin RNAs (shRNAs), cDNAs, and CRISPR
sgRNAs, as well as multiple automated robotic platforms for library manipulation. In addition, the Shared
Resource offers CRISPR/Cas9-mediated genome-editing services in a variety of cell types including induced
pluripotent stem cells (iPSCs) derived from cancer patients. The ever-expanding functionalities of
CRISPR/Cas9 that include gene targeting, genome modification, and transcriptional modulation, promise to
greatly benefit DLDCCC members and facilitate both mechanistic and exploratory investigations using cancer
cell models. Specific services provided by the GMCCM Shared Resource include cellular reprogramming,
large-scale automated manipulation and preparation of genomic libraries, utilizing individual
cDNA/shRNA/sgRNA vectors, and automated mammalian cell transfection and lentivirus production in arrayed
formats. Importantly, GMCCM assists DLDCCC members with highly customizable gene-editing services in
cells of their choice, from primary cells and established cell lines, to human pluripotent stem cells (hPSCs) and
cancer patient-derived induced PSCs. By housing these resources in a single, cohesive Shared Resource,
GMCCM allows investigators to employ myriad genomic and genetic platforms that are often cost- and labor-
prohibitive or simply not feasible for individual laboratories. This synergistic combination of expertise and
resources makes GMCCM an invaluable asset to the DLDCCC.